Understanding CPAP Effects in the Developing Airway

Abstract: Supplemental O2 therapy and non-invasive ventilation (e.g. continuous positive pressure support, CPAP) are two major life-saving modalities of respiratory care for the treatment of preterm infants with respiratory distress syndrome. Unfortunately, there are significant unintended consequences associated with clinical care. Supplemental O2 therapy specifically has long been recognized as a potent contributor to the pathogenesis of wheezing and asthma of former preterm infants ? these observations have led to efforts to titrate and minimize the usage of O2 in the NICU setting and a shift toward increased use of CPAP. The dilemma, however, is that virtually nothing is known about whether there are also any adverse side-effects of CPAP. In this proposal, we will utilize a novel neonatal mouse model of CPAP (developed in our lab) to test the hypothesis that there are indeed, long-term adverse consequences associated with CPAP, manifest as an increase in airway hyperreactivity (AHR). We further hypothesize that the mechanistic basis underlying the effects of CPAP on AHR involves a stretch-induced increase in low-molecular weight hyaluronan (HALMW) expression in airway smooth muscle. HALMW is a major component of the extracellular matrix and our data show that it initiates downstream signaling pathways leading to increased calcium signaling, hyperreactivity, and smooth muscle proliferation. In parallel studies, we also show that the HA- Ca2+ pathway is functional in age-appropriate (for preterm infants) human fetal airway smooth muscle cells. Interestingly, offsetting or counter-balancing the increased HALMW by exogenous delivery of high molecular weight HA (HAHMW) prevents the adverse effects of CPAP. The clinical safety of HAHMW has been tested in a variety of settings ranging from treating eye abnormalities in preterm infants to children with cystic fibrosis, and adults with asthma. Therefore, this proposal will utilize a novel mouse model of neonatal CPAP to highlight the mechanistic basis for the unintended consequences it has on airway function, and provide evidence demonstrating tremendous promise for HAHMW administration as a viable therapy for the treatment and prevention of wheezing and asthma in former preterm infants.

Public health relevance
An immature poorly functioning lung is a common life-threatening complication faced by most premature babies. Supplemental oxygen and positive pressure respiratory support (e.g. continuous positive airway pressure, CPAP) are two important therapies that are intended to assist the baby through the immediate postnatal period until the lungs can function properly. Some therapies, have unintended side-effects. Supplemental oxygen, for example, adversely affects lung development and predisposes the infant to asthma and wheezing later in childhood. The primary goal of this proposal, however, is to focus on an animal model of CPAP to determine if/ how it might also have similar long-term adverse effects on the lung. We propose that mechanical stretch imposed on the lung by CPAP activates mechanisms that cause the airways to become hyper-reactive, a characteristic feature of wheezing and asthma. The data from this proposal will be the first to offer some insight into how CPAP impacts airway reactivity and wheezing disorders in former preterm infants, while also revealing potentially promising targets to prevent such unintended effects of CPAP.